Xbeads: A Platform for Flow Cytometry Sample QC and Harmonization

Summary
Flow cytometry is a cornerstone of modern biomedical research and clinical diagnostics, offering
unparalleled insights into the human immune system. Its capacity to rapidly analyze thousands of cells per
second while simultaneously measuring dozens of parameters has made it indispensable for studying a
wide range of biological processes. However, the complexity of flow cytometry assays introduces
challenges in standardization and reproducibility. The variability in flow cytometry arises from several
factors, including instrumentation and setup, reagent stability and quality, and experimental methods. These
factors, especially in high-parameter experiments, can significantly impact assay results, hindering reliable
data comparison across time, instruments, and testing sites. To address these challenges, we developed
Xbeads, a novel internal assay quality control system. When added to samples prior to staining and
processing, Xbeads can assess the performance of the entire cytometry workflow, including sample
processing, data acquisition, and antibody reagent activity. By monitoring changes in Xbead signals, errors
can be identified and normalized to ensure quantitative comparability across different experimental
conditions. In our Phase I studies, we successfully demonstrated the utility of Xbeads in quantifying cellular
antigen expression. We developed tightly-defined Xbeads for different antigens that were stable during
storage and could be combined to create antigen cocktails. Xbeads effectively corrected for errors in
instrument setup, reagent degradation, and staining methods. In this Phase II proposal, we plan to expand
the Xbead system to include a broader range of validated antigens, encompassing both surface and
intracellular targets. We will also conduct a mock flow cytometry clinical trial to assess the ability of Xbeads
to normalize variation in a typical study using multiparameter staining panels. The successful completion of
the Phase II studies will yield a robust commercial offering of Xbeads that has been rigorously validated to
correct for instrument, reagent, and processing complexity. By addressing the challenges of assay
variability, we aim to enhance the reproducibility and utility of flow cytometry in both research and clinical
applications.

Public health relevance
Project Narrative Flow cytometry is a powerful single cell analysis platform that is widely used to study the human immune system in basic research and clinical trials. Here we propose to further develop an in-sample quality control platform that is capable of identifying and correcting variation in flow cytometry experiments due to instrumentation differences, assay performance, or reagent quality. This will improve the data obtained in human clinical trials and enable next generation analysis tools across large scale flow cytometry research studies.